Molecular Basis of Substrate Translocation in the Drug/H+ Antiporter 1 Family

Molecular Basis of Substrate Translocation in the Drug/H+ Antiporter 1 Family
Summary
Integral membrane proteins known as multidrug transporters extrude therapeutic drugs of diverse
chemical structures across cell membranes, impeding the treatment of human cancers, infectious
diseases, and neurological disorders. Currently we lack a deep and mechanistic understanding of how
these proteins export drugs or how they can be thwarted. We will study the structure and mechanism
of a model multidrug transporter, MdfA from Escherichia coli, which couples the influx of H+ to the
efflux of various antimicrobials and belongs to the ubiquitous Drug/H+ Antiporter 1 (DHA1) family.
MdfA orthologues are present in many pathogenic microorganisms, and the overexpression of E. coli
MdfA can lead to antimicrobial resistance in clinical patients. Thus, MdfA represents an important
target for therapeutic exploitation to overcome multidrug resistance. Furthermore, the SLC18
antiporters, which are the human counterparts of MdfA in the DHA1 family, conduct the H+-dependent
vesicular transport of monoamine neurotransmitters, polyamine neuromodulators, and neurotoxins.
The human SLC18 antiporters are essential for brain function and promising therapeutic targets for
battling alcoholism, autism spectrum disorders, bipolar disorder, Huntington disease, major depressive
disorder, Parkinson’s disease, schizophrenia, and Tourette syndrome. Our long-term objective is to
understand how the DHA1 multidrug transporters and human SLC18 antiporters translocate their
substrates and how their function can be modulated for potential therapeutic benefit. Notably, prior
biochemical studies have suggested that MdfA translocates certain substrates via a non-canonical
mechanism. Drawing upon these data and our experience in membrane protein structural biology, we
will accomplish two aims: (1) to elucidate the molecular basis for simultaneous translocation of two
mono-cationic substrates by a DHA1; (2) to reveal the structural mechanism for non-canonical, DHA1-
mediated extrusion of di-cationic therapeutics. By combining crystallographic and biochemical studies,
we will acquire new insights into how a DHA1 translocates two substrates concurrently, how a DHA1
inhibitor differs from the substrate, and how a DHA1 exports a therapeutic drug in two consecutive and
yet different deprotonation/protonation cycles. The new conceptual framework and DHA1 structures
obtained from this study will serve as a stepping-stone toward devising novel strategies to evade or
inhibit the clinically relevant multidrug transporters, which may rescue therapeutic efficacy against
multidrug-resistant cells and halt the spread of untreatable infections. Furthermore, our work will offer
a springboard for the mechanistic studies of human SLC18 antiporters, which will shed new light on
how they utilize the electrochemical H+ gradient to translocate monoamine neurotransmitters,
neurotoxins, or polyamine neuromodulators, across vesicular membranes.

Public health relevance
This project seeks a deep understanding of a major mechanism underlying multidrug resistance, which may inform new therapeutic strategies for combatting infectious diseases and human cancers. Our proposed work will also elucidate the molecular underpinnings of vesicular neurotransmitter and neurotoxin sequestration, which can facilitate the treatment of alcoholism, autism, bipolar disorder, Huntington disease, major depressive disorder, Parkinson’s disease, schizophrenia and other neuropsychiatric ailments.